CoARS Administrative Supplement

ABSTRACT
The specific aims of this proposal are to establish a coordinated infrastructure and research agenda for the
Consortium on Addiction Recovery Science (CoARS). These aims directly supplement the aims of the parent
grant award (R24DA051946-02). The parent grant was funded via NIDA's groundbreaking FOA (RFA-DA-20-
014) that sought to develop multi-stakeholder networks to advance the development of effectiveness research
on specific types of RSS, especially for individuals taking medications for opioid use disorder. NIDA awarded
five of these R24 grants, each focused on specific types of RSS for addiction. After being funded, these five
independent teams connected and decided to initiate an informal effort to optimize their collective expertise
and resources. This created CoARS, which has operated for one year in the funding margins of each R24. This
Administrative Supplement will provide direct funding and programmatic momentum to CoARS. The current
CoARS mission is to accelerate science on recovery support services for opioid and other substance use
disorders by building an infrastructure based on scientific, lived experience, and community program expertise
and resources. It is now timely and essential to establish a formal infrastructure through this supplement in
order to fully leverage the diverse resources and expertise of CoARS in order to maximize its collective
research productivity, diversity and equity profile, and sustainability as a national leader in the science of
addiction RSS. Supplemental Aim 1 consolidates the nascent CoARS infrastructure via protected time for
R24 scientists, coordination of the varied research and training efforts across the R24s, and creation of
communication and dissemination channels for R24 activities; underwriting the first national meetings on
addiction RSS science; and mapping pathways for CoARS sustainability. Supplemental Aim 2 supports
CoARS primary research initiatives. While each R24 included some aspect of research training, CoARS will
marshall cross-R24 training and peer learning to foster interaction among trainees at all stages (undergrad
through early career scientists) and professoinal identity (including community members). We also will create
toolkits to guide researchers in engaging more persons with lived experiences—e.g., in recovery, caregiving for
a person using substances and/or in recovery, justice involvement—in RSS research and training activities,
focusing on adapting techniques of community-based participatory research and research-practice partnership
for RSS contexts. We will also adopt the NIMHD Minority Health & Health Disparities Research Framework,
which focuses on groups with disparities in addiction and related areas and provides a structure to facilitate
analysis of the CoARS research portfolio to assess progress and opportunities, as well as harmonize research
methods and data sources across the five R24 grants in concert with HEAL Data Ecoystems guidelines.

Public health relevance
Project Narrative Addiction recovery support services (RSS) have operated at enormous scale for decades and recently become an emphasis of federal initiatives to address the opioid epidemic; however, rigorous research on the effectiveness and implementation of various RSS is alarmingly scarce. This Administrative Supplement will provide direct funding and programmatic momentum to the Consortium on Addiction Recovery Science (CoARS). CoARS will accelerate science on RSS for opioid and other substance use disorders by building an infrastructure based on scientific, lived experience, and community program expertise and resources.